Engage-D: DEsigNing Culturally Sensitive Care ManaGement for Hospice TrAnsitions for Diverse Persons LivinG with AdvancEd Dementia

ABSTRACT
Among the 6.5 million adults with Alzheimer’s disease and Alzheimer’s disease related dementias (AD/ADRD)
in the United States, nearly a third of persons living with dementia (PLWD) receive care in the home healthcare
setting, many of whom are at the end of life with advanced dementia. Many often benefit from transition to
hospice when eligible and aligned with goals of care. Despite the benefits of hospice care for PLWD such as
improved care quality, fewer hospitalizations, and increased care partner support, racially and ethnically diverse
PLWD have disparately low rates of hospice use. Black and Latino PLWD have greater hospitalizations and low
hospice use at the end of life. Little is known about disparities in hospice use for Asians due to a lack of data
stemming from underrepresentation in AD/ADRD research. Preferences, cultural and religious beliefs, lack of
access, and mistrust may explain some inequities in hospice use. Culturally sensitive care management for
hospice care transitions has potential to improve end-of-life care for diverse PLWD; however, gaps in evidence
preclude the development of such interventions to improve hospice transitions for racially and ethnically diverse
PLWD. Thus, care management interventions, informed by health disparities and health equity research
frameworks and by end-users such as home healthcare professionals and care partners, that can be integrated
into existing care delivery models, are urgently needed. Home healthcare is a crucial intervention point for
increasing hospice use; however, care management that aligns with values, preferences, religious, spiritual, and
cultural needs of PLWD and care partners requires further study. This K23 Mentored Patient-Oriented Research
Career Development Award will provide the candidate, Komal Patel Murali, PhD, RN, ACNP-BC, with training in
AD/ADRD intervention development and clinicals, health equity research, and career development to progress
on a pathway to independence as an interdisciplinary nurse scientist and aging researcher focused on improving
end-of-life care inequities impacting diverse PLWD and their care partners. The specific aims for this career
development award are to: 1) Co-design a culturally sensitive care management checklist to guide hospice
transitions for Black, Latino, and Asian PLWD and their care partners receiving home healthcare, 2) Pilot test
the culturally sensitive care management checklist within care management for feasibility, acceptability, fidelity,
and usability for Black, Latino, and Asian PLWD and care partners and HHC professionals, 3) Examine hospice
enrollment, time to enrollment, and care partner satisfaction at 1-month and 6-month follow up with Black, Latino,
and Asian PLWD and their care partners. This study is conceptually guided by the National Institute on Aging
Health Disparities Research Framework, the Equity-Focused Implementation Research Framework, and the NIH
Stage Model for Intervention Development. The intervention will be delivered within usual care management
surrounding hospice transitions within a large home healthcare agency in New York City and will inform the
development of a subsequent R01 clinical trial.

Public health relevance
PROJECT NARRATIVE This study aims to better understand how to deliver culturally sensitive care management for hospice care transitions involving racially and ethnically diverse persons living with the dementia and their care partners in home healthcare to generate needed evidence that can help reduce inequities in hospice use at the end of life. Informed by the National Institute on Aging Health Disparities Research and the Equity-Focus Implementation Research frameworks, this study aims to codesign and pilot test a culturally sensitive transitional care management checklist intervention to improve hospice transitions for Black, Latino, and Asian persons living with dementia and their care partners in home healthcare. Findings from this study will inform future transitional care interventions that can meet the needs of racially and ethnically diverse persons living with dementia surrounding hospice transitions and can be adapted for other healthcare settings.